Neuroimaging predictors of bariatric surgical outcomes

PROJECT SUMMARY/ABSTRACT
Bariatric surgery is an important treatment option for morbidly obese patients who fail to lose weight through
diet and exercise. Despite intervention, 20-50% of patients either fail to lose targeted amounts of weight or
regain weight that was lost initially. Attempts at predicting the degree of weight loss have had only modest
success and none have long term (>2 year) reliability. Moreover, there is a serious absence of research to
predict weight loss beyond the 1st or 2nd year post-surgery and for outcomes other than weight loss including
comorbidities common in the bariatric population. Our pilot data in 45 patients suggest that individual
differences on pre-surgical neural activity measured with functional MRI (fMRI) reliably explains s 33% of the
variance in weight loss up to 1 year post surgery, and over 50% of a multifaceted outcome measure, far
outperforming many other indicators. These brain activation predictors implicate regions that closely conform
to a theoretical model emphasizing both consummatory urges (a “Now” neural circuit) vs. regulation of craving
and self-control (a “Later” circuit). Our central hypothesis is that individual differences in these neural
pathways exert a powerful effect on the ability to sustain weight loss and achieve other key health outcomes.
This project seeks to replicate and refine this model over a longer timeframe and to assess its predictive utility
for key weight-related health outcomes.
We propose to replicate the model derived from our fMRI pilot data predicting weight loss and secondarily to
explore its predictive utility for changes in calorie intake, activity levels, liver fat, hemoglobin A1c, plasma lipids,
blood pressure, and fasting glucose in a new, independent cohort of N=150 successively consenting, pre-
surgical sleeve gastrectomy (SG) patients in study years 1-3. We will follow the pilot cohort for up to 7 years
and the new cohort for 3 or more years to determine if predictors replicated in Aim 1 retain their long-term
predictive power, particularly when supplemented with non-brain imaging variables and using a larger
longitudinal dataset. We will use imaging and non-imaging data to develop multivariate statistical models
incorporating energy balance, fMRI, and laboratory values with the variables described in Aim 1 to help to
separate predictors vs. consequences of post-surgical outcomes. To help separate scan-to-scan variability
from true post-surgical, trajectory-related brain changes, we will enroll N=20 obese subjects who will not
undergo bariatric surgery, and are individually matched with our above SG subjects. Finally, in terms of
translational potential, we will evaluate whether several related, non-fMRI cognitive tests that probe "Now vs.
Later" functional domains to our MRI paradigms might have the potential to act as surrogate tests in clinical
practice that help predict the likelihood of successful SG outcome during pre-surgical patient assessment.
These studies are highly significant both in terms of understanding the role of neural patterns in weight
regulation and in helping patients achieve bariatric population-specific health outcomes.

Public health relevance
PROJECT NARRATIVE Bariatric surgery is an important treatment option for morbidly obese patients; however, between 20 to 50% of patients either regain significant weight or fail to lose the anticipated amount of weight. Prior attempts to predict the degree of weight loss have had only modest success. Our pilot data in a surgical population suggest that individual differences on pre- surgical neural activity measured with functional MRI (fMRI) reliably predict weight loss and other bariatric patient-specific health outcomes up to 1 year later. Our central hypothesis is that these individual differences in these neural pathways exert a powerful effect on sustained weight loss at one year and beyond, and thus provide important insights into the mechanisms of weight loss and health outcomes following bariatric surgery.